Translational regulation by covalent modification of mRNA

Translational regulation by covalent modification of mRNA
Project Summary
Aging is a complex process that involves time-dependent loss of cellular functions resulting from
genomic and epigenetic instability, translational dysregulation, and altered intercellular communication.
Increased longevity and healthier lifespan can be promoted by altering expression of degradation-
related proteins, transcription factors, chaperones, and signaling molecules in cellular systems and
mouse models. For many compelling interventions, mitigating aging-related diseases in humans will
involve (i) upregulation of gene expression and/or (ii) inhibition of hard-to-drug or "undruggable"
proteins and ligands. Increasing protein cellular activity using small molecules and modulating the
expression of non-conventional targets are compelling unmet challenges in drug discovery. In
exploratory work in cells, we have consistently observed significant increases in reporter protein activity
in the presence of ligands that bind to and covalently react with a specific messenger RNA (mRNA).
Selective increases in protein expression by covalent modifications of mRNA would be a foundational
advance for the fields of anti-aging and RNA-targeted therapeutics. The developmental studies we
propose will also reveal fundamental mechanisms by which mRNA modifications in cells modulate
translation. We will explore this unanticipated and intriguing aspect of protein expression, and its
potential longer-term applications to aging, via the following two Aims: Through Aim 1, we will optimize
the translational effect of small molecule-mediated mRNA alkylation, and, through Aim 2, we will
establish the mechanism through which alkylation of an mRNA by a small molecule upregulates
expression of the encoded protein.

Public health relevance
Project Narrative Enabling longer, healthier lifespans by reversing or preventing cellular aging represents a transformative opportunity in biomedical science. Using small molecules that site-specifically and covalently react with mRNA, we have been able to achieve gene-specific increases in protein expression. In this exploratory research proposal, we will define the mechanism underlying this increase and exploit it to establish new strategies to address aging-related disease at the cellular level.